Malaria diagnostic testing and conditional subsidies to target ACTs in the retail sector: the TESTsmART trial

Project Summary—TESTsmART Trial
In 2016, the WHO estimated that 216 million cases of malaria occurred worldwide, yet more than 400 million
treatment courses of first-line antimalarials (artemisinin combination therapy or ACT) were consumed. This
substantial overuse of ACTs is driven in large part by the private retail sector. More than half of families in sub-
Saharan Africa seek treatment for febrile illness in retail medicine outlets where ACT is available over-the-
counter, but malaria diagnostic testing is virtually absent and presumptive treatment of fever as malaria is the
norm. Availability of inexpensive, donor-subsidized ACTs and the absence of diagnostic testing lead to very
poor targeting of ACTs to people who need them. Individuals without malaria consume between 65-90% of
ACTs distributed through retail outlets. Unnecessary consumption of ACTs is a drain on scarce public health
resources and threatens the future sustainability of publicly-funded subsidies. In addition, it puts both present
and future patients at risk by accelerating the spread of drug resistance. Although accurate point of care
diagnostics are available for malaria (called rapid diagnostic tests or RDTs), they are uncommon in the retail
sector and, where they have been tried, their impact on appropriate ACT use is often poor. We hypothesize
that both providers and clients’ decisions about testing and treatment are strongly influenced by price (or
profit). In response to this, we propose to test a scalable, policy-relevant strategy that integrates testing and
treatment subsidies for the client, with incentives to the provider to test for malaria. ACT subsidies will be
available only to customers with a positive malaria test (conditional ACT subsidy). Differential ACT pricing for
clients based on the results of the diagnostic test, combined with provider rewards for testing, will align both
consumers and providers incentives (price and profit) with testing and appropriate ACT use. In Aim 1, we will
use an individually-randomized experiment in Kenya to test the effect of two levels of RDT subsidies and two
levels of conditional ACT subsidies on testing uptake among retail outlet clients seeking treatment for malaria-
like illnesses. In Aim 2, we will scale-up the combination of testing and treatment subsidies that maximized
testing rates in Aim 1 and test their impact, along with incentives to providers’ for testing, on ACT targeting
using a cluster-randomized controlled trial in Kenya and Nigeria. Our approach will ensure that public subsidies
are directed at confirmed malaria cases thereby enhancing the sustainability of such programs. By allocating
subsidy dollars across both testing and conditional treatment (rather than universal, treatment-only subsidies),
we can reduce the cost of subsidizing malaria treatment and improve targeting of ACTs without compromising
access.

Public health relevance
Project Narrative—TESTsmART Trial The ultimate goal of the proposed work is to improve antimalarial stewardship in the retail sector, which is responsible for distributing the majority of antimalarials in sub-Saharan Africa. Through a combination of diagnosis and treatment subsidies for customers, and provider-directed incentives, our approach will align provider and customer incentives with appropriate case management. Targeting antimalarials to individuals with confirmed malaria could dramatically improve both individual and public health outcomes.